Diversity Supplement to PRIDE-AGOLD: Bias in/bias out in data sciences and health artificial intelligence

PROJECT SUMMARY: This supplement application does not change the Project Summary attachment that
was submitted in the proposal for the parent award.

Public health relevance
PROJECT NARRATIVE: This supplement application does not change the Project Narrative attachment that was submitted in the proposal for the parent award.